Administrative Supplement to Purchase an FT-IR Spectrometer

Funds are requested to replace a broken FT-IR spectrometer’s base unit. The old instrument was used
for every study conducted under the parent award due to the necessity of characterizing synthesized
compounds by FT-IR spectroscopy and disseminating that data in the literature. The proposed purchase
is of a Bruker ALPHA II base unit with a compact footprint that allows it to be housed inside a nitrogen-
filled glovebox, thus enabling measurements to be done under inert atmosphere for air-sensitive samples.
This setup matches the one used with the old instrument, a Bruker ALPHA I, whose diamond ATR and
transmittance sampling modules are fully compatible with the ALPHA II and do not need replacing.
Procuring the instrument and restoring the FT-IR experimental setup is critical to continuation of research
in the parent award. Examples in the Research Strategy illustrate the importance of FT-IR in case studies.

Public health relevance
Funds are requested for a Bruker ALPHA II FT-IR base unit to replace a broken ALPHA I unit in the PI’s lab. The purchase would restore an experimental setup that has been critical to research progress under the parent award.